Evaluating Efficacy of Antiseptic Mouth Rinses on Salivary SARS-CoV-2 Infectivity

ABSTRACT
Evaluating the antiviral potential of widely available commercial antiseptic rinses on SARS-CoV-2 infectivity holds
great potential for rapidly reducing viral transmission, particularly as novel strains emerge. Given that SARS-
CoV-2 is transmitted primarily through aerosols and salivary and respiratory secretions, strategies to reduce viral
burden is an attractive approach to mitigating spread; this is particularly true for dental and other healthcare
settings which have high patient volumes, require work in close proximity to the head and neck, and generate
procedural aerosols. Though studies have demonstrated that some antiseptic mouth rinses have antiviral
properties against SARS-CoV-2 in vitro and other enveloped viruses in vivo, data are still emerging from recent
randomized clinical trials (RCT), including ours at the Adams School of Dentistry, regarding whether antiseptic
mouth rinses reduce SARS-CoV-2 in vivo. To address this gap in knowledge, we propose to determine whether
mouth rinses containing ethanol, hydrogen peroxide, povidone-iodine, chlorhexidine, or cetylpyridinium chloride
reduce SARS-CoV-2 viral load, replication and infectivity (Aim 1) and to characterize salivary inflammatory and
antibody responses associated with early SARS-CoV-2 infection (Aim 2) using salivary samples derived from
our recent COVID-19+ patient RCT. Altogether, the data generated from these aims will demonstrate whether
antiseptic rinses reduce salivary SARS-CoV-2 viral load and infectivity, and will characterize the local
inflammatory response to SARS-CoV-2 in the oral cavity with the ultimate goal of limiting viral spread. These
studies will generate data to develop feasible, inexpensive, rapidly implementable protocols to mitigate the
spread of SARS-CoV-2 and address this urgent public health need with broad translational impact. Our
interdisciplinary team is uniquely qualified to conduct the proposed work as we have the innovative
methodologies, BLS2+ facilities, SARS-CoV-2+ samples, and expertise to achieve our aims. This application
includes collaboration between experienced and junior faculty across multiple disciplines to ensure the rigor and
translatability of our findings.

Public health relevance
NARRATIVE Identifying a commercially available mouth rinse with antiviral efficacy against SARS-CoV-2 would allow for rapid implementation of an oral rinse protocol to limit viral transmission in healthcare settings, essential workplaces, and social environments, with broad public health impact. We will characterize the oral inflammatory response of early SARS-CoV-2 infection by determining antibody and soluble protein levels in saliva, to see whether it impacts mouth rinse efficacy and to identify new diagnostic and prognostic biomarkers.